Predicting stuttering subtypes from functional connectivity using machine learning

PROJECT SUMMARY
Persistent developmental stuttering (PDS) is a neurodevelopmental motor speech disorder that disrupts a
speaker’s ability to produce fluent speech, characterized by acoustic disturbances, physical concomitants, and/or
avoidance behaviors. Over 50 million adults worldwide present with PDS with negative social, emotional, and
professional consequences. Adults who stutter (AWS) report mixed results with speech-therapy intervention,
with many who relapse in symptoms. There is high intra-individual and inter-individual variability in stuttering,
ranging from different disfluency types, frequency, contexts, and internal and external factors. Although there
have been many neuroimaging studies on stuttering, there is still a lack of consensus on the neural mechanisms
underlying the disorder. Specifically, there are a limited number of studies that differentiate disfluency distinct
stuttering behaviors, which may help characterize the variability in behavioral presentations. Thus, the
primary objective of the current project is to investigate the neural networks involved in stuttering through two
specific aims: 1) identify neural correlates of distinct disfluency types (repetitions, blocks, prolongations) using
resting-state functional magnetic resonance imaging (rs-fMRI) data, and 2) utilize machine learning (ML) and
traditional statistical methods to predict predominant disfluency types from resting state functional connectivity.
Aim 1 will develop stuttering profiles from speech samples and investigate neural correlates of disfluency types
in AWS using resting state functional connectivity data. Aim 2 will predict predominant disfluency types from
functional connectivity using ML and traditional statistical methods. The long-term goal is to develop
comprehensive stuttering profiles that capture the inherent heterogeneity of AWS for efficacious personalized
treatment interventions. The novel application of utilizing ML to predict stuttering disfluency types holds
substantial potential to advance the field of stuttering research and clinical practice by identifying patterns from
large datasets. This study will further our understanding of the neural substrates of stuttering, which is directly in
line with NIDCD’s mission to advance our understanding of normal and disordered speech and improve the lives
of individuals with communication disorders. Additionally, the second aim aligns closely with one of NIDCD’s
goals to develop ML algorithms to provide novel insights and applications for clinical populations.

Public health relevance
PROJECT NARRATIVE The purpose of this proposal is to characterize the neural correlates of stuttering disfluency patterns from speech samples and neuroimaging data. Machine learning and traditional statistical methods will be utilized to predict predominant stuttering disfluency types from resting state functional connectivity data. Thus, the proposed project will establish individual brain-behavior relationships in people who stutter to inform future personalized treatment interventions.